Deciphering the role of N6-methyladenosine (m6A) on mRNA during adaptive stress

ABSTRACT
Prostate cancer (PrCa) is the second leading cause of cancer related deaths in men. Current treatment methods
are no longer effective once cancer cells become resistant, allowing cells to progress to metastasis. Two markers
for worse patient outcomes in PrCa are the Integrated Stress Response (ISR) and the RNA modification N6-
methyladenosine (m6A). The ISR is an adaptive pathway that can be triggered by many stressors within cancer
cells and the tumor microenvironment. This pathway can be activated by cancer treatments and its activation
can lead to drug resistance and metastasis. The ISR serves as a protective mechanism that limits extraneous
protein synthesis and promotes the translation of select stress response and pro-survival transcripts. The
mechanism by which this adaptive translation occurs is relatively unknown, but one method by which mRNAs
may be selected for increased translation is through m6A. m6A methylation has been observed to alter the
splicing, degradation, localization, and translation of mRNAs. In PrCa cell lines, inhibiting m6A deposition leads
to growth deficiencies. Recent papers have tied the m6A methylation of specific transcripts to their translation
status during the ISR. The goal of this proposal is to determine if m6A modifications on select transcripts
are required for their translation during the ISR, and whether blocking m6A will sensitize PrCa cells to
targeted therapies. Here, two aims are proposed to determine the role of m6A modifications in marking
transcripts for translation during the ISR and to identify how the m6A machinery can drive PrCa. In Aim 1, m6A
sequencing will be carried out from polysome fractions with and without inhibition of the ISR to correlate the m6A
methylation state of a transcript during the ISR to its translation status. The top targets identified by the m6A
sequencing will be validated using a knockout of m6A writer METTL3 and qPCR of mRNAs derived from
polysome profiles. Potential impacts on mRNA degradation rates will also be determined by inhibiting
transcription and analyzing transcripts with and without the presence of m6A. Additionally, isolation of proteins
bound to specific regions of top target mRNAs followed by mass spectrometry with and without m6A will be
employed to determine which proteins bind m6A transcripts during the ISR. In Aim 2, four m6A regulatory
proteins—VIRMA, eIF3h, YTHDF3, and hnRNPA2B1—found to be significantly upregulated in PrCa datasets
and disease progression, will be evaluated. Correlations between their expression profile and oncogenic
potential in metastatic PrCa cells, alongside treatment with current PrCa therapies, will be analyzed in cells with
stable knockdown and overexpression of these genes. Lastly, the mechanism by which the proteins function will
be established by identifying the mRNAs they bind to and the possible downstream consequences of their
binding on mRNA translation during the ISR. Pursuing these aims will enable a detailed representation of the
role m6A plays in driving select mRNA translation during the ISR. Gaining an increased understanding of the
drivers of selective translation may provide novel insights into targeting strategies for treating advanced PrCa.

Public health relevance
PROJECT NARRATIVE Prostate cancer cells can activate adaptive pathways in response to oncogenic stress, allowing for therapy resistance, cell survival, and cancer progression. This proposal seeks to identify the mechanism by which cancer cells dynamically adapt to treatments through mRNA regulation with the goal of determining the best ways to inhibit this process. In identifying this regulation and recognizing ways to inhibit this adaptive stress response, potential therapeutic opportunities to prevent metastasis in prostate cancer can be identified.